Designer Molecular Probes for Biomedical Applications

PROJECT SUMMARY
For two decades the PI has led a research program developing molecular probes that have
yielded breakthroughs in Chemical Biology, Radiology, Cellular Genomics/Transcriptomics,
Anesthesiology, and Photochemistry. Since 2019, the PI has published 20 peer-reviewed
research manuscripts and 2 review articles with NIH-MIRA support, and several related papers.
The PI has mentored 2 postdoctoral fellows to successful job placement, 4 graduate students to
Ph.D. completion and chemistry careers, and 6 undergraduates to STEM Ph.D. programs. The
MIRA grant continues to provide primary support to 8 graduate students and 2 undergraduates
who are carrying out the studies that underpin this renewal application. The PI’s service
confirms a strong commitment to scientific review, undergraduate and graduate education,
outreach, community building, and junior faculty mentoring. This MIRA grant renewal will build
on several exciting advances made in the current funding cycle. In the first project, several new
small-molecule capsules and proteins have been developed for xenon binding. Key principles
have been elucidated for controlling the xenon exchange rate in these systems, and a suite of
new tools will drive the development of sensitive xenon contrast agents (Xe CAs) for molecular
imaging and also lead to improved understanding of xenon anesthesia and analgesia. Critically,
the FDA approved hyperpolarized Xe-129 for human lung magnetic resonance imaging (MRI) in
Dec, 2022. Imaging equipment has been assembled at UPenn with collaborators (Kadlecek and
Gade), and we propose to perform cutting-edge Xe-129 MRI studies and investigate Xe CAs
developed in the PI’s laboratory for lung cancer detection in mice. Notably, a Xe CA employing
ribose-binding protein (RBP) led to the discovery of 5 mM ribose in HeLa cells, 1000x more than
previously estimated. This has spawned a second project, which is the development of the first
useful fluorescence resonance energy transfer (FRET)-based sensor for real-time quantitation
of ribose levels in mammalian cells. This offers the opportunity to study natural fluctuations in
ribose (likely as a function of cell cycle), and also explore enzymatic pathways that we
hypothesize convert ribose-5-phosphate (originating from the pentose phosphate pathway) to
ribose. Finally, a third project stems from the development of fluorescein- and Cy5-labeled
siRNA molecules as first-in-class ratiometric pH probes for elucidating details of endosomal
entrapment and release and improving delivery of therapeutic oligonucleotides to skeletal
muscle. Novel bicyclic oligonucleotides are proposed for achieving potent enzyme inhibition.

Public health relevance
PROJECT NARRATIVE This project will develop powerful tools for molecular imaging of lung cancer via Xe-129 MRI, elucidating xenon-protein interactions important for anesthesia/analgesia, studying ribose metabolic pathways, and assessing cellular delivery of therapeutic oligonucleotides.